Core A: Administration

CORE A – ADMINISTRATION
PROJECT SUMMARY
The Administrative Core provides services that are critical to every member of the Program. This Core is the
administrative and organizational structure that the Principal Investigator uses to effectively manage and oversee
the entire Program. Core A supports an administrator for this Program Project as well as significant support for
a biostatistician. The administrator organizes the interactions between the Principal Investigator and any
collaborators who are not members of this Program Project. The administrator also assists the Principal
Investigator with management of the budgets, and acts as a liaison between the CSHL administrations. The
research administrator may also assist individual Project leaders with administrative tasks, including manuscript
preparation and submission of non-competing continuation reports. The Administrative Core serves as the
Program archive, collecting and storing published papers and all other Program related materials. This ensures
that all Program publications be placed into the public domain via PubMed Central. The Core A administrator
and/or bioinformatics personnel assist in depositing large datasets to the appropriate repository upon publication
(e.g., GEO for next-gen sequencing or array datasets). Core A also is responsible for organizing interactions
with both an internal and external advisory committee to advise the Principal Investigator and Project Leaders
on strategies and approaches, as well as planning for the future.

Public health relevance
CORE A – ADMINISTRATION PROJECT NARRATIVE Core A is responsible for organizing the different components of this Program Project. It provides the infrastructure that organizes Program meetings, oversees Program expenditures, and enriches the scientific environment of the Program. Core A also provides access to a biostatistician to assist investigators within the Program.